Development of a Direct Diagnostic Test for Infectious and Congenital Syphilis

PROJECT SUMMARY
Current diagnostic tests for syphilis are non-optimal, in that they cannot differentiate active from past
infection, cannot diagnose congenital syphilis, and have low sensitivity in early and late disease. With
the number of infectious and congenital syphilis cases rapidly expanding in the US and worldwide,
curbing the spread of disease will be aided by development of a better diagnostic test that is definitive,
easily interpreted, and compatible with a point-of-care test format. In this research application we
propose to develop a direct syphilis diagnostic test that: (1) exhibits high sensitivity and specificity at all
disease stages; (2) can differentiate active versus past infections; (3) can differentiate syphilis from
yaws; (4) can allow accurate disease staging; and (5) can be adapted to a point-of-care format for ease
of testing in remote areas.

Public health relevance
PROJECT NARRATIVE Syphilis affects millions of people worldwide, and its global rates are on the rise. Current diagnostic tests for syphilis are non-ideal, and having a better diagnostic test would lead to more infections being detected and a decreased incidence of disease. In the current proposal we will extend the performance testing of our promising, newly developed syphilis diagnostic platform that is highly specific for detection of infectious and congenital syphilis and can be translated to a point-of-care test format, to aid in achieving the goal of decreasing the incidence of syphilis in the US and worldwide.